SAXS Core

The mission of the SAXS Core facility is to provide support to research projects from CCR principal investigators (PIs), NIH intramural PIs, and extramural academic research groups/laboratories. The support includes providing routine access to the APS PUP SAXS/WAXS beamline and in-house SAXS instrument, and expertise in experimental design, data collection, processing, analysis, and interpretation. Our main focus is to determine the structure of biomacromolecules and their complexes in solution. The research field includes but not limited to structural studies of nucleic acids, proteins, protein assemblies, virus particles, lipid membranes, protein/DNA, and protein/RNA complexes. The publications that have used the SAXS Core services for this review period are the following: Publication list of SAXS Core in period of July 2019- July 2020 1. Zhang, Y., Zhang, Y., Liu, Z. Y., Cheng, M. L., Ma, J., Wang, Y., Qin, C. F. & Fang, X. Long non-coding subgenomic flavivirus RNAs have extended 3D structures and are flexible in solution. EMBO Rep 20, e47016, doi:10.15252/embr.201847016 (2019). PMID: 31502753; PMCID: PMC6832101 2. Yonkunas, M. J. & Baird, N. J. A highly ordered, nonprotective MALAT1 ENE structure is adopted prior to triplex formation. RNA 25, 975-984, doi:10.1261/rna.069906.118 (2019). PMID: 31113838, PMCID: PMC6633196 3. Song, H. & Ji, X. The mechanism of RNA duplex recognition and unwinding by DEAD-box helicase DDX3X. Nat Commun 10, 3085-3093, doi:10.1038/s41467-019-11083-2 (2019). PMID: 31300642; PMCID: PMC6626043 4. Song, H., Dharmasena, M. N., Wang, C., Shaw, G. X., Cherry, S., Tropea, J. E., Jin, D. J. & Ji, X. Structure and activity of PPX/GppA homologs from Escherichia coli and Helicobacter pylori. Febs J, doi:10.1111/febs.15120 (2019). PMID: 31679177; PMCID: N/A 5. Martin, J. E., Le, M. T., Bhattarai, N., Capdevila, D. A., Shen, J. C., Winkler, M. E. & Giedroc, D. P. A Mn-sensing riboswitch activates expression of a Mn2+/Ca2+ ATPase transporter in Streptococcus. Nucleic Acids Research 47, 6885-6899, doi:10.1093/nar/gkz494 (2019). PMID: 31165873;PMCID: PMC6649816 6. Li, S., Su, Z., Lehmann, J., Stamatopoulou, V., Giarimoglou, N., Henderson, F. E., Fan, L., Pintilie, G. D., Zhang, K., Chen, M., Ludtke, S. J., Wang, Y. X., Stathopoulos, C., Chiu, W. & Zhang, J. Structural basis of amino acid surveillance by higher-order tRNA-mRNA interactions. Nat Struct Mol Biol 26, 1094-1105, doi:10.1038/s41594-019-0326-7 (2019). PMID: 31740854;PMCID: PMC6899168 7. Kim, S. K., Whitley, M. J., Krzysiak, T. C., Hinck, C. S., Taylor, A. B., Zwieb, C., Byeon, C. H., Zhou, X., Mendoza, V., Lopez-Casillas, F., Furey, W. & Hinck, A. P. Structural Adaptation in Its Orphan Domain Engenders Betaglycan with an Alternate Mode of Growth Factor Binding Relative to Endoglin. Structure 27, 1427-1442 e1424, doi:10.1016/j.str.2019.06.010 (2019). PMID: 31327662;PMCID: PMC6726503 8. Kaustov, L., Lemak, A., Wu, H., Faini, M., Fan, L., Fang, X., Zeng, H., Duan, S., Allali-Hassani, A., Li, F., Wei, Y., Vedadi, M., Aebersold, R., Wang, Y., Houliston, S. & Arrowsmith, C. H. The MLL1 trimeric catalytic complex is a dynamic conformational ensemble stabilized by multiple weak interactions. Nucleic Acids Res 47, 9433-9447, doi:10.1093/nar/gkz697 (2019). PMID: 31400120; PMCID: PMC6755125 9. Tauber, M., Kreuz, S., Lemak, A., Mandal, P., Yerkesh, Z., Veluchamy, A., Al-Gashgari, B., Aljahani, A., Cortes-Medina, L. V., Azhibek, D., Fan, L., Ong, M. S., Duan, S., Houliston, S., Arrowsmith, C. H. & Fischle, W. Alternative splicing and allosteric regulation modulate the chromatin binding of UHRF1. Nucleic Acids Res, gkaa520, doi:10.1093/nar/gkaa520 (2020). PMID: 32609811 10. Song, H., Dharmasena, M. N., Wang, C., Shaw, G. X., Cherry, S., Tropea, J. E., Jin, D. J. & Ji, X. Structure and activity of PPX/GppA homologs from Escherichia coli and Helicobacter pylori. Febs J 287, 1865-1885, doi:10.1111/febs.15120 (2020). PMID: 31679177 11. Shin, J. H., Sulpizio, A. G., Kelley, A., Alvarez, L., Murphy, S. G., Fan, L., Cava, F., Mao, Y., Saper, M. A. & Dorr, T. Structural basis of peptidoglycan endopeptidase regulation. Proc Natl Acad Sci USA 117, 11692-11702, doi:10.1073/pnas.2001661117 (2020). PMID: 32393643; PMCID: PMC7261138 12. Ray, A., Edmonds, K. A., Palmer, L. D., Skaar, E. P. & Giedroc, D. P. Staphylococcus aureus glucose-induced biofilm accessory protein A (GbaA) is a monothiol-dependent electrophile sensor. Biochemistry-Us, doi:10.1021/acs.biochem.0c00347 (2020). PMID: 32697076 13. Jaynes, J. M., Sable, R., Ronzetti, M., Bautista, W., Knotts, Z., Abisoye-Ogunniyan, A., Li, D., Calvo, R., Dashnyam, M., Singh, A., Guerin, T., White, J., Ravichandran, S., Kumar, P., Talsania, K., Chen, V., Ghebremedhin, A., Karanam, B., Bin Salam, A., Amin, R., Odzorig, T., Aiken, T., Nguyen, V., Bian, Y., Zarif, J. C., de Groot, A. E., Mehta, M., Fan, L., Hu, X., Simeonov, A., Pate, N., Abu-Asab, M., Ferrer, M., Southall, N., Ock, C. Y., Zhao, Y., Lopez, H., Kozlov, S., de Val, N., Yates, C. C., Baljinnyam, B., Marugan, J. & Rudloff, U. Mannose receptor (CD206) activation in tumor-associated macrophages enhances adaptive and innate antitumor immune responses. Sci Transl Med 12, doi:10.1126/scitranslmed.aax 6337 (2020). PMID: 32051227 14. Hauseman, Z. J., Harvey, E. P., Newman, C. E., Wales, T. E., Bucci, J. C., Mintseris, J., Schweppe, D. K., David, L., Fan, L., Cohen, D. T., Herce, H. D., Mourtada, R., Ben-Nun, Y., Bloch, N. B., Hansen, S. B., Wu, H., Gygi, S. P., Engen, J. R. & Walensky, L. D. Homogeneous Oligomers of Pro-apoptotic BAX Reveal Structural Determinants of Mitochondrial Membrane Permeabilization. Mol Cell 79, 68-83 e67, doi:10.1016/j.molcel.2020.05.029 (2020). PMID: 32533918 15. Chen, M. R., Pan, H., Sun, L. F., Shi, P., Zhang, Y. K., Li, L., Huang, Y. X., Chen, J. H., Jiang, P., Fang, X. Y., Wu, C. Y. & Chen, Z. C. Structure and regulation of human epithelial cell transforming 2 protein. Proc Natl Acad Sci USA 117, 1027-1035, doi:10.1073/pnas.1913054117 (2020) PMID: 31888991; PMCID: PMC6969500